LIFE'S NEW FRONTIER: PUBLIC HEALTH GENETICS PHASE I/II

DESCRIPTION (provided by applicant): The Tech Museum of Innovation and Stanford University School of Medicine Department of Genetics have established long-term partnership to enable the public to draw connections between modern genetics research and choices they face about their health. Together we will develop, produce, evaluate, and disseminate Life's New Frontier, a dynamic exhibition which will inform the public about the goals and methods of modern genetics. Interactive permanent exhibits and guided learning centers, staffed jointly by museum educators and by working scientists (predominantly Stanford graduate students and postdoctoral fellows), will take the public into the minds and laboratories of scientists who are revolutionizing biomedical science. The exhibition and associated public and school programs will emphasize the emerging discipline of bioinformatics, which is fundamental to the Human Genome Project, gene-based diagnosis, rational drug design, and treatment of disease. Life's New Frontier will open in the summer of 2003 to reach an estimated 1.5 million diverse people annually through museum and online visitation. It will set a new standard for the treatment of cutting-edge science in exhibitions by establishing an infrastructure that permits rapid changes to exhibit content, and creating opportunities for visitors to receive personalized science and health updates after their visit. The exhibition also will serve as a platform to foster continuing personal interaction among middle and high school students, Stanford faculty and students, and the general public. The Tech/Stanford partnership will be maintained through staff liaison positions at each partner institution and will be evaluated to assess its effectiveness. We hope to extend this model to other departments at the Stanford University School of Medicine, and to disseminate it as a model for other science center/university partnerships in biomedical sciences. We anticipate significant outcomes of this partnership: the public will be better able to apply the ideas of modern genetics to decisions about their health; and a broad range of students from diverse backgrounds will be inspired to pursue biomedical education and research.